The impact of early life adversity on brain network development in youth

PROJECT SUMMARY
Early life adversity (ELA), such as physical or sexual abuse, witnessing a crime, family conflict, or community
violence, can have prolonged effects and significantly increases the risk for later psychopathology.
Experiencing such adversity can result in a wide range of psychiatric disorders, which have been found to be
more resistant to treatment. Further complicating intervention efforts, some youth exposed to ELA continue to
show normal functioning and behavior over time (“adaptive” or “resilient”), while others show increasing
psychiatric symptoms and go on to develop psychiatric disorders (“vulnerable”). The factors and
neurobiological mechanisms that underlie this variability and that prospectively identify those at greatest risk
are not yet well understood. This is a critical knowledge gap in the ability to help youth who have experienced
early life adversity. Recent research suggests that youth with ELA have abnormal function and connectivity
within and between 3 core brain networks which support emotional reactivity and cognitive-emotional control -
the salience network (SN), frontoparietal network (FPN), and default mode network (DMN), and changes in
these networks are associated with a wide range of psychopathology. To date, however, no study has
systematically examined the relative developmental trajectories of these core networks, how they are altered
by ELA exposure, and how such alterations relate to the expression of general psychopathology risk and
unique dimensions of internalizing vs. externalizing. The proposed study addresses these gaps of knowledge
by examining the association between ELA, FPN, DMN, and SN network development, and both overall
psychopathological load as well as specific dimensions of psychopathology using data from a large cohort
(n=11,873) of adolescents from the Adolescent Brain Cognitive Development (ABCD) study. Demographic,
environmental, and behavioral data are acquired every year and neuroimaging data are acquired every 2
years, starting at age 9-10y. This is a critical developmental period, the entrance into puberty, characterized by
both a rapid emergence of psychiatric disorders as well as sex differences in the prevalence of internalizing
and externalizing disorders. The function and interaction of SN, FPN, and DMN are examined both at rest and
during cognitive load to determine the extent to which ELA-related network alterations are modality specific.
Data are analyzed using both model-based and data-driven methods. Finally, this research uses both model-
based prediction and machine learning to determine potential early predictors of later psychopathology.

Public health relevance
PROJECT NARRATIVE The outcome of this study will provide crucial insights into the neurobiological changes that could account for the broad range of psychiatric disorders in youth who have experienced high early life adversity, as well as the differences between those who are more versus less vulnerable. Knowledge of these factors and mechanisms would enable the early identification of at-risk youth, allowing novel and timely prevention strategies, and the development of personalized interventions for adversity-exposed youth that target the specifically affected neural and biological pathways.